Post-Irradiation Telomere Shortening and Therapeutics to Maintain Vaccine Immunity

Identify radiation-induced DNA damage, in the form of shortening of telomers, as a biomarker of injury and prevent the death of memory T cells to maintain immunity following radiation exposure